Swine in Biomedical Research Conference 2024

Project Summary/Abstract
The overarching mission of the conference series is to foster the exchange and translation of scientific
information relevant to the utility of pigs as translational models for the elucidation of human disease mechanisms
and for the development and validation of clinically relevant therapies and medical devices. The Swine in
Biomedical Research Conference 2024 will be held at the University of Wisconsin Memorial Union, Madison,
Wisconsin, June 14–18, 2024. The location, with its current level of biomedical research, provides a thematic
backdrop and the collaborative network for reaching out to and attracting broader demographics of attendees,
including many of those affiliated with the biomedical industry. The specific aims of this conference are to: (1)
engage clinician researchers and biomedical scientists, (2) identify unmet clinical needs or existing gaps in
research that require innovative swine models, and (3) increase diversity and ensure the continued growth of
the biomedical swine research community. A central goal of the planning is to increase the inclusion of nationally
underrepresented groups (esp. women and minorities) and to encourage the participation of trainees (graduate
students and postdocs) and early-stage researchers. The outcomes of the conference will be: (a) a white paper,
published in a scientific journal, that assesses the current state of the biomedical swine research field and
identifies needs or demands for biomedical swine models, swine research facilities, resources, and expertise in
the United States, and (b) a report summarizing results of meeting surveys to assess the outcome of the
conference (including the number of researchers newly introduced to biomedical swine models, number of new
collaborations facilitated by the conference) and areas for future growth (including potential new programs to
engage underrepresented groups).

Public health relevance
Project Narrative The overwhelming biological similarities between pigs and humans, and the recent development of efficient genome editing tools, such as the CRISPR/Cas9 platform, has increased the utility of pigs as translational models for the elucidation of human disease mechanisms and for the development and validation of clinically relevant therapies and medical devices. This application requests partial support for the Swine in Biomedical Research Conference 2024 (8th in the conference series) to be held at the University of Wisconsin Memorial Union, Madison, Wisconsin, June 14–18. The conference aims to engage human medical scientists/clinicians and veterinarian researchers/animal scientists to identify unmet clinical needs and existing gaps in research that require innovative swine models and to foster new interdisciplinary collaborations.